Mechanisms of enhancer-promoter communication, genome organization and transcription control

ABSTRACT
Metazoan genomes achieve complex gene control by uncoupling regulatory DNA elements from target
promoters and allowing regulation at a distance. Thus, a gene can be differentially expressed in different cell
types and under different environmental signals or developmental cues. How distal regulatory elements
(enhancers) target specific gene promoters, how the search process is shaped by the topology of the genome
in the nucleus and how enhancer-promoter interactions are facilitated by regulatory complexes that relay
signals to the RNA Polymerase II and control transcription activity remains a mystery. Our goal is to
understand molecular and biophysical mechanisms that enable enhancer-promoter communication in human
and other mammalian cells. Towards these goals and during the period of this award we will accomplish the
following: (i) visualize the dynamic communication of enhancers and target promoters simultaneously with the
association of regulatory complexes and gene activity, using novel single-molecule and super-resolution
approaches for non-invasive 4D imaging of structure and function of the genome in single live cells; (ii)
determine mechanisms by which different classes of architectural proteins shape genome folding, enhancer-
promoter communication and transcription kinetics; (iii) dissect the function and interdependencies of individual
constituent enhancer elements within complex regulatory landscapes controlling cell identity genes. Our results
will establish quantitative frameworks for understanding the biochemistry of transcription regulation in the
crowded environment of the nucleus and for interpreting gene regulation and genome organization using soft-
matter/polymer physics and related biophysical concepts. These conceptual leaps are needed to ultimately
understand physical chromatin organization at sub-Mb scales, the scale most relevant for regulatory genome
interactions. Our integrated structure-function approach will provide functional validation and critical tests for
gene “regulation-at-a-distance” models. The proposed studies will not only provide substantial new knowledge
on the mechanisms of promoter-enhancer communication but will also set the stage for further studies of the
interplay of genome topology/organization and gene expression regulation.

Public health relevance
PROJECT NARRATIVE The communication between gene promoters and distal enhancers is essential for proper cell function, while often aberrant enhancer function leads to transcription deregulation and disease, however how enhancers target specific promoters remains unknown. This project will leverage new optical imaging technologies to directly visualize, with molecular detail, the dynamics of enhancer-promoter communication and downstream gene transcription control, in the nucleus of single live mammalian cells. A better understanding of the relation between genome organization and gene expression regulation will provide new opportunities for therapeutic and preventive interventions.